EPIDEMIOLOGY & BIOSTATISTICS CORE

The Epidemiology-Biostatistics Core: During its existence at PSM, this Core activity has been able to acquire the necessary sophisticated hardware, equipment, as well as other resources, needed for the full implementation of the Core services. Further, this Core has effectively implemented a Tee-for-Service